External Innovative Network Core

Project Summary
The External Network core (D) develops research networks around CDHA’s signature research themes and
extends the impact of CDHA resources and scientific findings to broader scientific, policy, and lay communities.
Core D staff organize and conduct seminars, conferences, workshops, and other special events that build diverse
intellectual communities around our core substantive research themes and related methodological issues. This
core oversees CDHA’s collaboration with other research units at UW-Madison as well as comparable research
centers at partnering institutions nationwide. It also oversees CDHA’s broad outreach activities designed to
engage a set of investigators from diverse career stages, disciplines, and institutions. It does so by sponsoring
new-user workshops for data resources led by CDHA affiliates, offering professional development travel awards
that enable emerging scholars to attend conferences and facilitate networking and collaboration; and providing
technical assistance and consulting to external affiliates on preparing funding applications to NIH.

Public health relevance
Project Narrative Per funding announcement instructions, the narrative is in the Overall section of this proposal.